Understanding Mechanisms of Organic Reactions and Processes through Imaging

Project Summary
A mechanistic understanding of reactivity has enabled the development of nearly all modern synthetic organic
chemistry, which has in turn revolutionized the discovery and production of therapeutics to treat human diseases.
Yet, traditional ensemble analytical tools for investigating mechanisms, like NMR spectroscopy and mass
spectrometry, measure primarily the major components in mixtures and provide averaged and non-spatially
resolved information, thus missing key reaction intermediates and distributions of behaviors. Approach: Here,
focusing on two challenging systems—aqueous–surfactant emulsions for sustainable organic chemistry in water
and the synthesis of organometallic reagents and catalytic intermediates directly from metal powders—we now
develop fluorescence lifetime imaging microscopy (FLIM) methods. These methods overcome the limitations of
prior analytical techniques and, we propose, lead to exciting insights into previously poorly understood classes
of organic reactions and processes. Innovation: The experiments described here are the first FLIM studies of
any synthetic organic chemistry reactions or processes under preparative conditions. We innovate by using this
spatially resolved fluorescence lifetime data to characterize reaction intermediates, assign fates of catalysts,
understand reaction mechanisms, and create predictive reaction models. Significance: Information gained from
these FLIM studies provides guiding principles for surfactant selection and medium recycling in sustainable
aqueous–organic systems, efficient methods for accessing organometallic reagents, and tactics for lowering
temperatures, ligand quantities, and/or catalyst amounts in carbon–carbon bond-forming cross-coupling
reactions. We focus our efforts on understanding and developing areas of high significance: organozinc,
organocopper, and organopalladium reagent and/or catalytic intermediate syntheses, as well as Negishi, Suzuki,
and Heck cross-coupling reactions, with applications in the synthesis of drug-like molecules. Beyond uncovering
guiding principles, we plan to develop next-generation chemical imaging agents and strategies, including
autofluorescence methods that function in the absence of exogenous imaging agents. Instead, these methods
will harness the inherent fluorescence lifetime and emission signatures of native reaction components. Once
developed, these imaging tools will be primed for use by our laboratory and others for the broader study of
mechanisms and processes in synthetic organic chemistry. Expertise in our diverse team uniquely encompasses
fluorescence microscopy, FLIM, organic synthesis methods development, transition-metal chemistry, catalysis,
surface characterization, and mechanistic studies—exactly the angles needed for the success of this ambitious,
multidisciplinary proposal, as demonstrated by robust preliminary results and an impactful publication record.
Together, these studies have a positive impact because they lead to efficient, sustainable routes for the
construction of carbon–carbon bonds and organometallic reagents and catalysts, thus facilitating the next
generation of therapeutic agents used to treat human diseases.

Public health relevance
Project Narrative The new imaging methods that will result from the proposed research are relevant to public health because they provide fundamental information that enables the efficient and sustainable preparation of compounds for drug discovery. The fundamental insight from these studies is relevant to NIGMS’s mission because the increased accessibility of these pharmaceutical candidates lays the foundation for advances in disease treatment.